Biomimetic Nitric Oxide and Hydroxyapatite Duo for Advanced Direct Pulp Capping

PROJECT SUMMARY
Direct pulp capping (DPC) offers an effective vital pulp therapy (VPT) for managing minimal, asymptomatic
pulp exposures, with the potential to prevent disease progression and reduce the need for invasive procedures
such as root canals, extractions, and extensive prosthetics. Current DPC materials, such as bioceramics and
calcium silicates, show limitations in providing bioactive functions essential for pulp healing, including
vascularization, mineralized barrier formation, and antimicrobial/anti-inflammatory effects.
To overcome these limitations, we propose a novel biomimetic nitric oxide and hydroxyapatite (NO-HA) duo,
utilizing a sequential application of NO-releasing peptide amphiphiles (PA-NO) gel and HA-fortified peptide
amphiphiles (PA-HA) gel. Our team’s preliminary data indicate that PA-NO has robust antibacterial, anti-
inflammatory, pro-angiogenic, and stem cell differentiation capabilities. Additionally, HA provides dimensional
stability due to its low solubility, calcium and phosphate tunability, resorption resistance, and radiopacity,
potentially supporting dentinogenic differentiation of dental pulp stem cells when used alongside NO.
Therefore, we hypothesized that the biomimetic NO-HA duo would synergistically enhance bioactive
and physical-mechanical barrier functions, providing a promising DPC solution for VPT. PA-NO will initiate repair
by promoting vascularization and delivering antimicrobial and anti-inflammatory effects, while PA-HA will function
as a mineralized barrier to stabilize the pulp-dentin interface and support dentinogenesis.
In Aim 1, we will 1) characterize PA-HA’s physical-mechanical properties including viscoelasticity,
compressive strength, solubility, and marginal adaptation, and 2) evaluate PA-NO’s bioactive functions for
vascularization, dentinogenic differentiation, mineralization, and inflammation. In Aim 2, we will assess the
feasibility and efficacy of the NO-HA duo in a rat pulp exposure model. The proposed biomimetic NO-HA duo
aims to 1) support pulp-dentin repair through vascular network formation and dentinogenic response and 2)
establish a stable, mineralized barrier with clinically relevant physical-mechanical properties.
This preclinical study represents the first application of engineered NO and HA as bioactive DPC materials
and will provide critical evidence for designing future large-scale studies and clinical trials. The biomimetic NO-
HA duo could enable pulp-dentin repair while preserving tooth vitality, reducing invasive and irreversible tooth
loss, and enhancing patient outcomes, with implications for cost savings and advancements in dental pulp
regeneration.

Public health relevance
PROJECT NARRATIVE The proposed nitric oxide and hydroxyapatite (NO-HA) combination offers an innovative solution to enhance direct pulp capping procedures, supporting pulp tissue repair and promoting the formation of a stable mineralized barrier for vital pulp treatment. By utilizing NO’s wound healing ability, including antimicrobial, anti-inflammatory, and angiogenic potentials, along with HA’s physical and mechanical strength, the NO-HA duo has the potential to greatly improve dental treatment outcomes. This advancement could help preserve natural teeth, prevent tooth loss, and reduce the need for invasive procedures such as root canals, implants, or dentures.